AGT001 for Delayed Graft Function in Kidney Transplantation

Project summary
Delayed graft function (DGF) is a form of acute kidney injury (AKI) that affects up to 50% of deceased-donor
kidney transplant recipients. Because of the organ shortage crisis, marginal or expanded criteria for donor
kidneys are increasingly considered even though these kidneys are at higher risk to develop DGF. There are no
FDA approved treatments for DGF available to date. Treatment or prevention of delayed graft function, therefore,
poses an unmet clinical need and new approaches to prevent and attenuate DGF are urgently needed. DGF is
largely caused by acute proximal tubular injury induced by ischemia/reperfusion injury.
Angiotensin converting enzyme 2 (ACE2) is a tissue monocarboxypeptidase abundant in the kidney proximal
tubule that, among other substrates, cleaves the amino acid phenylalanine from Angiotensin (Ang) II to form Ang
1-7. With deficiency of ACE2, Ang II accumulates, and the excess of this peptide results in increased
inflammation, fibrosis, and oxidative stress, all of which are features of acute kidney injury (AKI) and the AKI
associated with DGF. We have strong preliminary data in a preclinical mouse model of DGF caused by 3 hours
of cold ischemia prior to syngeneic kidney transplantation showing that ACE2 distribution in the kidney is
profoundly altered. The membrane bound form of ACE2 is lost from the apical brush border of tubular cells and
deposited in the tubular lumen and excreted in the urine. Decreased kidney ACE2 suggests a contributing effect
to the causation/severity of DGF that could be targeted therapeutically by administering a suitable form of soluble
ACE2. To deliver ACE2 to the kidney and thereby lower Ang II levels our lab designed a soluble ACE2 protein
bioengineered to pass the glomerular filtration barrier by shortening the native form to only 618 amino acids This
truncate was later fused with an Albumin binding domain (ABD) to extend the duration of action from hours to
days. Our preliminary data show that prior administration of this protein, termed AGT001, to mice that develop
DGF after syngeneic kidney transplantation results in kidney protection as shown by reduced blood urea nitrogen
(BUN) and reduced kidney Ang II levels.
In this proposal, we will determine the dosing of AGT001 for efficacy and safety when given perioperatively to
attenuate DGF in mouse syngeneic and allogeneic kidney transplantation models. The proposed work will lay
the foundation for transplantation of human donor kidneys enriched with ACE2 activity in-vivo as a strategy to
mitigate DGF and expand the use of marginal kidney donors. Successful completion of the proposed studies will
support a Phase II STTR application and eventually advancement of this therapy to IND-enabling studies. Our
ultimate goal is to submit AGT001 to the FDA for consideration for first-in-human clinical safety trials.

Public health relevance
Project Narrative Delayed graft function (DGF) is a form of acute kidney injury that affects up to 50% of deceased-donor kidney transplant recipients. We have robust preliminary data from a preclinical mouse model of DGF that Angiotensin Converting Enzyme 2 (ACE2) distribution in the kidney is altered and decreased and its substitution using a novel soluble ACE2 protein (AGT001) improves renal function. We will evaluate different dosing and schedules of AGT001 to improve DGF in mouse models of syngeneic and allogeneic kidney transplantation to further validate this therapeutic approach and lay a strong foundation for moving such molecular entity to the clinic.